Optimizing Therapeutic Revascularization by Endothelial Cell_Transplantation

Project Summary
This diversity supplement will support the work of Sadiyah Parveen, a PhD candidate in
biomedical engineering, to develop innovative drug delivery materials for controlled release of
proteins and nucleic acids, tested within our 3D bioprinted engineered skin model. The primary
objective of the parent grant is to create systems capable of safely and reliably releasing growth
factors and mRNA. While the initial focus was on using alginate and poly(amine-co-esters)
(PACE) materials, recent discoveries of the new material, poly(PEGMA), will offer enhanced
functionality, including prolonged and triggered release. Specifically, alginate microparticles,
although biocompatible, often exhibit burst release kinetics, whereas poly(PEGMA), with its
stable chemical cross-linking and tunable properties, offers a promising alternative for sustained
protein release. Additionally, current cationic polymer-based systems (i.e., PACE) provide
sustained mRNA release but require further optimization for extended delivery. Poly(PEGMA)
microparticles, with their hydrogel-like properties and controlled degradation, can potentially
maintain therapeutic mRNA levels for longer durations, thereby promoting better vascularization
and tissue regeneration. In aim 1, we will engineer microparticles composed of poly(PEGMA), a
synthetic brush-type polymer with pendant polyethylene glycol (PEG) ligands, to encapsulate
and release vascular endothelial growth factor (VEGF) in a sustained manner. These
poly(PEGMA) microparticles will be compared to alginate microparticles from the parent grant.
We hypothesize that poly(PEGMA) microparticles will provide superior control over protein
release kinetics compared to alginate, resulting in improved vascularization within 3D bioprinted
human skin constructs. In aim 2, we will focus on developing poly(PEGMA) microparticles that
enable controlled or triggered release of mRNA polyplexes to transfect endothelial cells (ECs),
promoting vascular growth and maturation. These new systems will be evaluated for their ability
to slowly release mRNA encoding Bcl2, an anti-apoptotic protein, and will be compared to the
PACE nanoparticle systems studied in the parent grant. We hypothesize that poly(PEGMA)
microparticles loaded with mRNA polyplexes will achieve efficient and controlled delivery of Bcl2
mRNA, enhancing EC viability and functionality within 3D bioprinted skin constructs. Overall,
this project leverages the synergistic expertise of our team to advance the development of non-
immunogenic, engineered tissue systems. By focusing on new drug delivery materials, we aim
to enhance the therapeutic potential of 3D bioprinted skin constructs, addressing critical needs
in tissue engineering and regenerative medicine.

Public health relevance
PROJECT NARRATIVE As in the parent grant, the supplement address a problem that is common to tissue engineering of all vascularized replacement organs, namely how to incorporate a functional microvascular system for organ perfusion. We will introduce two new innovations in this supplement: (1) we will use a new versatile degradable polymer material for delivery of growth factors, particularly VEGF, in a time and spatially controlled fashion within our 3D bioprinted skin; and (2) we will use an innovative strategy for controlled, slow extracellular release of mRNA polyplexes, which will allow us to provide weeks long expression of mRNA, creating prolonged Bcl2 expression (which we have previously show to dramatically enhance vascular maturation), providing safer, more transient expression than is possible with viral vectors.